Optimizing HIV-malaria treatment in a shifting treatment and resistance landscape in Africa

Project Summary
Malaria and HIV remain major challenges in sub-Saharan Africa (SSA), and the risk of co-infection remains
high; complicated by drug-drug interactions, the potential for overlapping adverse events, as well as
bidirectional negative clinical impacts. For HIV, a near universal transition to dolutegravir (DTG)-based
regimens is occurring across the lifespan in SSA. While an improvement over existing regimens, emerging
data clearly link DTG with increases in body mass index and metabolic derangements. Prospective studies of
such changes in SSA pediatric settings are scarce and must be conducted to ensure that early life exposure to
DTG does not lead to potential longer-term negative health impacts in HIV-infected children. SSA also bears
the majority of the world's malaria burden. Treatment relies on artemisinin-based combination therapies
(ACTs), of which artemether-lumefantrine (AL) and amodiaquine-artesunate (AS-AQ) are most utilized in SSA.
ACTs combine a potent short-acting artemisinin derivative with a long-acting partner drug, an approach that
has improved efficacy for the immediate episode, but also provides some protection against new exposures to
infectious bites after treatment is completed. We have demonstrated reductions in piperaquine, another
important ACT partner drug when given with DTG, and anticipate reductions will occur with AL and AS-AQ.
Such bidirectional interactions must be urgently assessed in children to avoid any unintended negative
consequences on malaria and HIV outcomes. Unfortunately, resistance to artemisinin, the critical backbone of
all ACTs, has now been detected in multiple African countries, including Uganda, further emphasizing the need
to optimize treatment regimens. For the partner drug lumefantrine, our group has demonstrated that
pharmacokinetic (PK) exposure is a strong predictor of the risk of re-infection, and that less susceptible
parasites are able to tolerate higher concentrations of drug. Similar studies are necessary for the artemisinin
derivatives, which vary in PK for each ACT regimen, and for amodiaquine, a component of AS-AQ. Our group
has led critical PK and pharmacodynamic (PD) studies aimed at informing the optimized use of ACTs in the
most vulnerable populations for malaria, especially young children and those with HIV living in high
transmission settings. To ensure that antimalarial and antiretroviral therapy remain optimized in the current
shifting landscape, we propose to establish four longitudinal pediatric cohorts with the goal of 1) assessing the
impact of HIV/DTG and repeated malaria infection on weight gain and the development of metabolic
abnormalities in Ugandan children, 2) determining the PK of DTG and/or ACTs in HIV-uninfected children and
HIV-infected children and their bidirectional clinical impacts, and 3) determining whether ACT PK is a driver of
drug resistance selection. Our studies aim to ultimately inform guidelines on the appropriate management of
both HIV and malaria in pediatric populations in SSA during period of transition to DTG and emerging
artemisinin resistance.

Public health relevance
Project Narrative HIV and malaria continue to place a tremendous burden in sub-Saharan Africa. The current treatment landscape for both diseases is changing with the near universal transition to dolutegravir for HIV, and the emergence of artemisinin resistance. Through the establishment of four hree longitudinal cohorts in Uganda, we will assess the impacts of dolutegravir on weight gain and metabolic derangements, the magnitude and impact of drug-drug interactions between dolutegravir and leading antimalarial regimens, and finally assess the pharmacologic predictors of resistance selection.